Resource Section

Project Summary – Resource Section
The role of the Genome Editing resource Section will be to validate unique reporter models created by RFA-
RM-18-013 and to provide animals and animal support for the Testing Section. Additionally, the Resource
Section will be responsible for procurement or production of animals and surveillance of biosecurity. The
Resource Section will maintain breeding colonies and produce cohorts of experimental animals. Further, the
Resource Section will be responsible for assembly and maintenance of BSL2 facilities for use by the
Testing Section. Our group is ideally suited to provide this testing due to our unique composition of
individuals that are experienced with pig production, swine biomedical models, operate successful labs that
routinely test cutting-edge genome editing technology, and are associated with world-renowned National
Swine Resource and Research Center (NSRRC). The Resource Section will have a significant impact on
the overall Swine SCGE Center’s ability to accurately assess new technologies and further facilitate the
ability to use genome editing in therapeutic circumstances.